PREVENTION OF ALCOHOL AND OTHER DRUG USE AMONG MIDDLE SCHOOL STUDENTS

This study proposes to delay the onset and prevent the use of alcohol and other drugs by middle school students by a multi-component intervention that includes curriculum, school environmental change and teacher and staff training, and family components.